The effect of virtual reality-based food marketing on biological hunger signals and purchase intention in young adults

PROJECT SUMMARY
This Mentored Research Scientist Development (K01) Award will support my long-term goal of becoming an
independent investigator who specializes in examining the techniques food companies use to market unhealthy
products to Black communities, with a specific focus on advanced digital technologies, such as virtual reality (VR). Food
marketing has been unequivocally linked to poor diet and risk of excessive weight gain in young people. Food
companies disproportionately target Black consumers with more advertisements (“ads”) and the least healthy ads,
contributing to nutritional disparities and nutrition-related diseases. To expand their reach, food companies have
developed VR marketing experiences that are engaging, highly sophisticated, and may more powerfully elicit biological
signals precipitating a motivation to consume foods. Although most food marketing studies focus on children and
adolescents due to their inability to recognize persuasive intent, Black young adults may be especially vulnerable to the
effects of food marketing exposure due to being highly targeted, shifts during this developmental period, and
food/nutritional insecurity. No study has examined the effect of VR food marketing exposure on biological signal
activation and purchase intention among Black young adults, or the interactions with food/nutritional insecurity. To
address these gaps, I have developed the following specific aims/hypotheses. Aim 1 will be to determine the extent to
which VR food marketing influences purchase intention and whether effects are more pronounced in Black young adults.
I hypothesize that exposure to VR food marketing will influence purchase intention versus the VR non-food control, and
Black (versus white young adults) exposed to VR food marketing will demonstrate higher purchase intention. Aim 2 will
be to understand the influence of biological signal activation on the relationship between VR food marketing and
purchase intention. I hypothesize that larger electrodermal amplitude and higher salivary reactivity will lead to stronger
purchase intention in those randomized to VR food marketing versus the control and that the effects will be more
pronounced among those with higher weight. Aim 3 will be to explore the interactions among race/ethnicity,
food/nutritional insecurity, biological signal activation, and purchase intention among Black young adults exposed to VR
food marketing. I hypothesize that those reporting low/very low food security will demonstrate stronger electrodermal
amplitude and higher salivary reactivity when exposed to the VR food marketing condition versus all others. I will develop
a community-based young adult advisory board to assist with interpretation of the results. It will be necessary to obtain
mentorship and training in VR, integrating biological measurements into an experimental paradigm, and applied
statistical analyses for biological outcomes to complete this project and develop the critical research competencies to
elucidate how advanced digital food marketing strategies influence nutritional disparities and nutrition-related disease
risk among Black young adults. Findings can inform novel behavioral interventions and regulatory efforts, such as the
Federal Trade Commission’s initiative to reduce stealth digital food marketing targeting vulnerable groups.

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to elucidate the effect of unhealthy food and beverage marketing as a key environmental determinant that places Black young adults at increased risk for nutritional disparities and nutrition-related chronic diseases, including type 2 diabetes, hypertension, and some cancers. The proposed research will evaluate the extent to which exposure to virtual reality (VR)-based food marketing influences biological signals (i.e., electrodermal activity and salivation) and purchase intention following a lab-based randomized experiment in a sample of Black and white young adults. Findings can inform novel behavioral interventions and current regulatory efforts, such as the Federal Trade Commission’s initiative to reduce stealth digital food marketing targeting vulnerable groups.